Discovering Network-Based Drivers of Single-Cell Transcriptional State in Tumor Immune Microenvironment to Reveal Immuno-Therapeutic Targets and Treatment Synergies

Project Summary/Abstract:
Solid tumors consist not only of tumor cells, but also of immune cell types infiltrating the tumor micro-
environment. Traditional approaches to cancer therapy have focused on killing tumor cells directly, but recent
immune checkpoint inhibitor therapies have instead aimed to activate anti-tumor immune cells in the tissue.
Immunotherapy has been transformative in clinical oncology over the past several years, but biomarkers of
response are limited and effect of treatment on tumor micro-environment is incompletely understood. This has
motivated efforts by Drake lab and others to better profile immune cell types in tumors under various treatment
conditions, aiming to reveal novel therapy targets and identify improved predictors of treatment response. Our
group has considerable experience applying high-throughput single-cell RNA sequencing (scRNA-Seq) to profile
tumor micro-environment with full transcriptional resolution at the level of individual cells. We hypothesize that
profiling the tumor microenvironment at single-cell level and applying an advanced network-based analysis
pipeline to treatment-naïve and immunotherapy-treated tumors will improve characterization of the
transcriptional program in tumor-infiltrating immune cell types, their association with outcome, and their clinically
relevant interactions with tumor cells. Aim 1) Despite high resolution, scRNA-Seq data are typically sparse, with
a minority of genes detected in any given cell. We aim to develop a powerful set of tools originating in the Califano
Lab for network-based inference of regulatory protein activity in single-cell data, mitigating gene expression
dropout and providing a scalable pipeline for inference of cell populations, tumor-immune interactions, and
regulatory proteins differentially activated in distinct cell states. We validate this pipeline by comparison to
markers concurrently profiled by flow cytometry in a dataset of clear cell renal carcinoma (ccRCC) patients. Aim
2) We will specifically leverage our novel analysis pipeline to interrogate drivers of tumor-infiltrating regulatory
T-cells, an immunosuppressive population induced by multiple conventional treatment modalities, including
androgen deprivation therapy in prostate cancer. We will validate predicted tumor-infiltration drivers by CRISPR
knockout screen and apply an advanced transcriptional perturbation screen to identify drugs which invert the
tumor-specific Treg signature. These are expected to serve as prime candidates for future combination
immunotherapy studies. Aim 3) We will identify changes in micro-environment induced by immunotherapy in
responders and non-responders across two clinical trials of immunotherapy plus androgen deprivation in prostate
cancer and one trial of anti-PD1 plus anti-IL1b in ccRCC, identifying potentially novel therapeutic targets. In
addition, we will apply our newly developed analytic pipeline to published scRNA-Seq datasets to identify
predictors of treatment response in melanoma. With joint guidance from experienced mentors in Immunotherapy
and Computational Systems Biology in the setting of Columbia University Medical Center, this project will prepare
the trainee for a career as a physician-scientist with a unique background in translational bioinformatics research.

Public health relevance
Project Narrative: In the short term, this project will provide a novel network-based analytic framework for improved mining of single-cell RNA-Sequencing data, enabling discovery of clinically relevant cell states and their proteomic regulators in the tumor microenvironment. In the field of cancer immunotherapy this will enable improved development of treatment response biomarkers based on single-cell transcriptional signatures, as well as concurrent discovery of druggable targets up-regulated in cell types associated with treatment resistance. For immunosuppressive populations that are not currently druggable, such as tumor-infiltrating regulatory T-cells, the experimental validation of predicted tumor-infiltration marker proteins may present a novel class of immunotherapies with utility in combination with checkpoint immunotherapy or other treatment modalities, and drugs predicted from perturbational screening of FDA-approved compounds could be rapidly translated in follow-up clinical trials.